Pediatric Gastroparesis Registry 2 Study (PGpR2) supplement

PGpR2 ABSTRACT
Study Overview:
Title: The GpCRC Pediatric Gastroparesis Registry 2 (PGpR2): Characterization and Clinical
Course of Symptoms and Gastric Emptying in Pediatric, Adolescent, and Young Adult
Participants with Symptoms of Gastroparesis
Study Purpose:
This observational, multi-center, prospective Registry study is designed to delineate the clinical
trajectory of pediatric, adolescent, and young adult patients (ages 8–25) exhibiting symptoms
indicative of gastroparesis (Gp), such as nausea, vomiting, early satiety, bloating, and abdominal
pain, irrespective of gastric emptying status. This study is anticipated to take up to 3 years.
Study Aims:
• Primary Objective: To document the demographic, clinical, and symptom profiles, as
well as the overall morbidity and progression of illness over time, in participants with
symptoms of Gp.
• Secondary Objective: To evaluate and compare clinical, physiological, and
psychological differences between participants with confirmed delayed gastric emptying
(gastroparesis) and those with Gp-like syndrome (GLS) but normal gastric emptying.
Methods:
The PGpR2 study has established a national Registry collecting standardized demographic,
clinical, physiological, and patient-reported outcome measures. GP-specific symptom severity
and quality of life are assessed longitudinally over a 48-week period using the Pediatric GI
Symptom Index (Including BARF Retching Scale), Rome IV Diagnostic Questionnaire for
Pediatrics FGIDs and PedsQL™ 3.0 Gastrointestinal Symptoms Scales™, the primary outcome
tool.
Study Leadership and Scope:
Baylor College of Medicine / Texas Children’s Hospital is serving as the coordinating center. A
total of 216 participants will be enrolled over a three-year recruitment period across six academic
sites participating in the NIH/NIDDK Gastroparesis Clinical Research Consortium. The full
duration of the study is five years, which includes recruitment, follow-up (up to three years per
participant), and data analysis.

Public health relevance
Project Narrative Gastroparesis is a gastrointestinal motility condition characterized by delayed stomach emptying, frequently accompanied by persistent nausea, vomiting, early satiety, and abdominal discomfort, significantly affecting quality of life. The Pediatric Gastroparesis Registry 2 seeks to enhance the original registry by conducting a comprehensive assessment of symptoms, gastric motility, patient demographics, and disease burden, while longitudinally monitoring this cohort to gain a deeper understanding of the condition's natural history and to facilitate future research, including clinical trials and mechanistic investigations. The PedsQL Gastroparesis Symptoms Module Multicenter Field Testing aims to evaluate the feasibility, reliability, and validity of a newly developed assessment tool for pediatric gastroparesis patients, with our site currently pursuing IRB approval to commence participant enrollment.